Novel pH-Sensitive Particles for Noninvasive Upper GI Tract Microbiota Sampling

Applied Research Project 2 – Project Summary
Research involving assessment of the upper gastrointestinal tract microbiota is restricted by the difficulty in being
able to accurately sample this space noninvasively. Currently, animal experiments interested in probing this
population requires sacrificing the animal, negating the possibility of longitudinal monitoring of the microbiome.
This method is particularly problematic when exploring the impact of a medical intervention, pre/pro-biotic use,
and/or dietary change where observation of alterations to the microbiota population over time are required. In
this case, animal cohorts must be euthanized at each time point greatly increasing the number of animals used
while not providing an actual internal standard for these longitudinal studies. There exists a considerable need
for a technology that can facilitate the periodic and selective noninvasive sampling of the upper gastrointestinal
tract. The long-term objective of our research is to leverage our expertise in materials engineering to create a
novel microbiota capture system that selectively samples only the upper gastrointestinal tract before safely
passing into the stool where it can be harvested and analyzed using a standard technique like 16S rRNA
amplicon sequencing. Specific Aim 1 will build upon our previous efforts generating a pH-sensitive poly(amino
acid)-grafted magnetic particle system to allow for the generation of different particle sizes with greater changes
in pH-sensitive surface charge with the option to include antibody-mediated capture components to the particles.
In Specific Aim 2, the in vitro, ex vivo, and in vivo performance of our first-generation upper gastrointestinal tract
sampling technology, as well as follow-on generations of this technology, will be assessed. After selective
capture has been achieved, longitudinal studies can be completed that will explore the impact antibiotic treatment
alone or in combination with a fecal transplant have on the change of the upper gastrointestinal tract microbiota
over time. The successful completion of these studies will not only yield a product that will have a tremendous
impact on in the animal research community but could be readily translated for use in the clinic for companion
animal, productional animal, and human applications in the relatively near future.

Public health relevance
Applied Research Project 2 – Narrative The upper gastrointestinal bacteria drive many metabolic and disease processes in mice and humans but there is currently no published method to noninvasively sample and monitor microbiota in the upper intestine. The goal of this project is to develop and characterize a biocompatible polymer coated magnetic bead system that is pH sensitive to selectively capture the bacteria of the upper small intestine and be able to isolate and analyze the bound bacteria from feces using standard metagenomic profiling. This technology has broad implications for not only the biomedical research community but also possible human clinical applications for disease, infection, and probiotic monitoring.